Artificial Intelligence assisted echocardiography to facilitate optimal image extraction for congenital heart defects diagnosis in Sub-Saharan Africa

Artificial Intelligence assisted echocardiography to facilitate optimal image
extraction for congenital heart defects diagnosis in Sub-Saharan Africa
Summary
Sub-Saharan Africa (SSA) accounts for over 50% of all global under-5 deaths. Congenital
anomalies (CAs), notably congenital heart defects (CHD) which constitutes about a third of all
(CAs), are a major contributor to this high under-5 morbidity and mortality in SSA. Late and missed
diagnosis, owing to the lack of experts who can perform an echocardiography scan, remains the
primary challenge to CHD diagnosis and care in SSA. Recently, there have been increased
uptake CHD screening in newborns by pulse oximetry. However, the test is nonspecific and still
requires expert confirmation through echocardiography. The few expert paediatric cardiologist
centres that exist are often located hundreds of kilometers away from the birthing centres, placing
enormous financial and physical burden on parents who must undertake this journey to confirm
their baby’s diagnosis, and not leaving out the particularly fragile and vulnerable neonate who
may end up dying in the course of the journey. Training programs have been demonstrated to
improving image capture and recognition of the anomaly. However, such programs are labor and
time intensive and need to be repeated with staff turnover. A complementary strategy is therefore
needed to improve and sustain the gains from training. In line with the DSI-Africa’s mission to
address critical health gaps through the application of data science, our proposed project seeks
to leverage modern advances in data science and artificial intelligence (AI) to address the problem
of CHD diagnosis in SSA by creating the possibility for low skilled sonographers to conduct an
echocardiography scan for neonates (0-28 days) and extract optimal images that can be
subsequently transmitted to a remote expert for interpretation. This means local non-experts (e.g
GPs, nurses, midwives) serving the birthing centres will now be able conduct postnatal
echocardiography scans for neonates suspected of having a CHD after pulse oximetry screening,
allowing them to obtain optimal labeled images/video clips that can be transmitted to a remote
expert for diagnosis confirmation. This will remove the burden and risk of travelling hundreds of
kilometers, increase early diagnosis and initiation of care remotely, and reduce the workload on
the few available experts. Future steps will include extending to prenatal diagnosis and predicting
actual diagnosis.

Public health relevance
Artificial Intelligence assisted echocardiography to facilitate optimal image extraction for congenital heart defects diagnosis in Sub-Saharan Africa Narrative Congenital heart defects (CHD) is a major contributor to under-5 deaths in Sub-Saharan Africa (SSA), owing to the lack of paediatric cardiologist experts who can perform an echocardiography scan for early diagnosis. The current project seeks to develop an artificial intelligence assisted model that will allow local non-experts such as nurses who work in birthing centres, to conduct an echocardiography scan and extract optimal images which can sent to a remote expert for interpretation and diagnosis confirmation. This will remove the burden and risk of travelling hundreds of kilometers to expert centres mainly located in cities, increase early diagnosis and initiation of care remotely, and reduce the workload on the few available experts.